Admin Core

Modified Project Summary/Abstract Section

The North Carolina Central University (NCCU) seeks competitive renewal of its RCMI - Center for Health Disparities Research (RCHDR) to continue enhancing NCCU's research ecosystem to develop investigators who are conducting impactful and cutting-edge biomedical and behavioral research for better health outcomes for all populations, The Center is an interdisciplinary effort at NCCU housed at the Julius L. Chambers Biomedical/Biotechnology Research Institute (BBRI). In this renewal application, a concerted effort was made to establish a strong leadership team for the RCHDR through a group of senior- and mid-level experienced individuals. The Center will be comprised of four Cores: Administrative Core (AC); Research Capacity Core (RCC) (arranged into 5 sub-cores); Investigator Development Core (IDC) and Community Engagement Core (CEC) supporting one basic and one behavioral full biomedical research project plus pilot studies.

Public health relevance
Modified Public Health Relevance Section Persistent gaps in access to quality care among U.S. communities contribute to worsening health outcomes and remain a critical public health challenge. The role of HBCUs in addressing and being represented in the community has proven to be essential to address health challenges through research and community engagement. Through this competitive renewal, NCCU's RCMI Center for Health Disparities Research (RCHDR) will continue enhancing NCCU's research ecosystem to develop successful scientists conducting impactful and cutting-edge research that aim to improve health outcomes for all populations.